Cytokine JAK-STAT Signaling in Immunity and Disease

? DESCRIPTION (provided by applicant): Support is requested for a Keystone Symposia meeting entitled Cytokine JAK-STAT Signaling in Immunity and Disease, organized by Curt M. Horvath, John J. O'Shea and Stephanie S. Watowich. The meeting will be held in Steamboat Springs, Colorado from January 10-15, 2016. Cytokines are important extracellular factors that direct a variety of biological responses in normal physiology and disease. Cytokine signaling is mediated in large part through four Janus kinase (JAK) proteins and seven Signal Transducer and Activator of Transcription (STAT) proteins, and these molecules intersect with a wide array of additional intracellular signals to drive significant global alterations in gene expression. Cytokine JAK-STAT pathways are intimately associated with innate and adaptive immunity, inflammation, stem cell and developmental biology, and diverse aspects of cancer biology. As JAK-STAT pathways produce both common and unique phenotypes critical for a vast range of biological phenomena, the basic understanding of how these signal transduction cascades are regulated, function and integrate with additional cellular responses has been continuously refined by discoveries of general and pathway-specific mechanisms. Furthermore, drug discovery efforts have produced small molecules targeting JAKs and STATs that are promising agents in clinical treatment of inflammation, arthritis and a variety of cancers. This meeting, coinciding with the 25th year of the discovery of JAK-STAT signaling, will couple invited speakers who have made significant contributions to allied disciplines with both cytokine JAK-STAT veterans and newcomers to the field, with ample opportunities for short talks selected from submitted abstracts.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cytokine JAK-STAT signal transduction is the basis of immune system development and deployment, pathogen recognition and response, and the immunological interface with allergy and inflammatory processes. Indeed, most multicellular phenomena from development to disease feature essential roles for JAK-STAT signaling. The Keystone Symposia meeting on Cytokine JAK-STAT Signaling in Immunity and Disease is designed to reflect the expansion of our understanding of cytokine-JAK-STAT signaling from basic research to clinical relevance and pharmaceutical and therapeutic applications. This meeting represents a unique opportunity for researchers in these allied fields to interact with each other, filling a critical need for this field that has experienced a fast rise from discovery o clinical application.